Advanced Research Training in Immunology for Surgery Trainees (ARTIST)

Project Summary/Abstract
The Advanced Research Training in Immunology for Surgery Trainees (ARTIST) is a specialized training
program that responds to the accelerating demand for expertise at the intersection of surgery and translational
immunology research and the critical need to ensure a pipeline of surgeon-scientists. The long-term goal of
the program is to inspire and train the next generation of surgeon-scientists who will lead immunology research
focused on solutions for clinical problems relevant to tissue injury, repair, regeneration and replacement.
Discoveries by these surgeon-scientists are anticipated to lead to new tools for diagnosis or prognosis of
immune-mediated diseases and also to new immunotherapies. Program objectives are achieved by
recruitment of outstanding trainees with innate curiosity and the aspiration to become leaders in surgery,
selection of high quality interdisciplinary and collaborative NIH-funded faculty, and innovative didactics and
professional development activities. Eligible trainees are competitively selected from an outstanding pool of
surgery residents (postdoctoral trainees) in the Ohio State University (OSU) General Surgery residency
program who have completed at least two years of clinical training. The diversity of the surgical trainee pool is
a strength of the ARTIST program since the diversity of its research trainees will contribute greatly to the
quality and diversity of the future biomedical research workforce. Surgical trainees work with the program
director, faculty and staff to prepare for the research experience far in advance of the training period in order to
optimize their research success and productivity. Each trainee dedicates a minimum of two years without
clinical responsibilities to conduct mentored research, to undergo didactic training in the OSU COM Masters of
Medical Science advanced degree program and to participate in professional development activities. Following
completion of the research training program, trainees proceed to another two to three years of advanced
clinical training. During this time they continue to publish, present at national meetings, compete for awards
and participate in research and professional development activities associated with the program. With this
renewal application, we are requesting funds for training four postdoctoral trainees per year for Years 1
through 5. Core requirements to earn the MMS degree include coursework in Immunology, Research Design,
Biostatistics, Grant Writing, and Research Ethics. Trainees are also required to take two newly developed
courses “Career Development for Surgeons” course and “Applications of Immunology in Surgery” journal club.
Significant programmatic attention is directed to seamless integration of the clinical and research training
programs, ensuring the quality and rigor of the curriculum, facilitating opportunities to enhance science
communication skills, creation of innovative educational assessment tools, careful evaluation of individual
trainee progress and collective evaluation of program outcomes.

Public health relevance
Project Narrative Optimal outcomes after surgery may be impaired due to immune mechanisms which cause tissue injury or interfere with healing. The goal of this program is to inspire and train the next generation of surgeon-scientists who will lead immunology research focused on solutions for clinical problems relevant to tissue injury, repair, regeneration and replacement. Discoveries by these surgeon-scientists are anticipated to lead to new tools for diagnosis or prognosis of immune-mediated diseases and also to new immunotherapies which improve surgical outcomes.